Molecular Determinants of liver sinusoidal endothelial cells for hepatic regeneration

ABSTRACT
End-stage liver disease is associated with morbidity and mortality often requiring a liver transplant. Dysfunction
and capillarization of liver sinusoidal endothelial cells (LSECs) could contribute to impaired hepatic repair and
cirrhosis. Thus, uncovering the mechanisms by which LSECs acquire their specialized functions to support
hepatic repair could enable the development of therapies for scar-free liver repair. We have shown that
activation of Id1 and Cxcr7 in LSECs induce angiocrine factors, that guide hepatic regeneration without
fibrosis. However, the mechanism by which LSECs acquire their pro-hepatic functions is unknown. We show
that while transcription factors (TFs) Fli1 and Erg dictate the vascular fate and homeostasis of LSECs (Gomez-
Salinero JM, et al, Nature Cardiovascular Research, 2022), induction of TF c-Maf specifies the phenotype and
regenerative functions of LSECs (Gomez-Salinero JM, et al, Cell Stem Cell, 2022). Induction of c-Maf in
generic human endothelial cells (ECs) switches on liver-specific LSEC signatures and angiocrine factors
supporting hepatocyte functionality. In mice in which c-Maf is deleted in adult ECs, recovery from CCl4 results
in fibrosis and LSECs regression to arterial cell fate. Thus, we hypothesize that maintenance of LSEC vascular
cell fate requires constitutive Fli1 or Erg expression, sustaining LSECs homeostatic functions. Induction of c-
Maf enforces specialized pro-regenerative functions and interactions of LSECs with hepatocytes, Kupffer and
stellate cells that prevents stress-induced LSEC arterialization promoting hepatic repair without fibrosis. To this
end, we have reprogrammed human generic ECs to an adaptable tubulogenic state. These Reset-Vascular
Endothelial Cells (R-VECs) self-assemble into a 3D vascular network, transporting human blood and arborizing
hepatocytes (Palikuqi B et al. Nature, 2020). The vascularized hepatic aggregates with stellate and Kupffer
cells within scalable and perfusable microfluidic devices establish a human Hepatic-on-VascularNet platform,
enabling study of physiologically adaptive cross-talk between human hepatocytes and LSECs. This
hypothesis will be tested by performing these Aims: Aim 1: Define the mechanism by which hierarchical Fli1
and Erg expression through c-Maf induction sustains specialization of LSECs at steady state, during hepatic
regeneration and after CCl4 induced liver injury. AIM 2: Uncover the contribution of c-Maf expressed in the
Kupffer cells that by enforcing and sustaining LSEC vascular attributes regulate hepatic homeostasis during
liver regeneration and CCl4 induced liver injury. AIM 3: Employ the human Hepatic-On-VascularNet platform to
uncover the mechanism by which c-Maf is induced functionally in human liver ECs to form specialized LSECs.
Determine whether human c-Maf induced LSECs (iLSECs) can restore hepatic regeneration. Specifically, the
role of infusing human iLSECs in restoring hepatic repair post-acetaminophen (APAP) injury without provoking
fibrosis will be assessed. These studies will uncover the molecular determinants of human LSECs and allow
strategies to employ iLSECs to sustain its pro-regenerative and anti-fibrotic attributes for liver repair.

Public health relevance
Narrative Dysfunction of the specialized liver endothelial cells that line blood vessels could lead to loss of hepatocytes and scarring setting the stage for the progression of advanced liver disease, which is incurable except with a liver transplant, that is an expensive and challenging procedure. We have found previously unknown key factors, namely the transcription factors Erg, Fli1, and c-Maf, capable of specifying naïve mouse or human endothelial cells into functioning specialized liver sinusoidal blood vessels; that will enable approaches to uncover the signals that drive liver regeneration without causing scarring. We have proposed studies to decipher the underlying mechanisms by which the endothelial cells by vascularizing stellate, Kupffer cells and hepatocytes conduct their crosstalk, thereby setting the stage for designing strategies for a more effective and scar-free hepatic regeneration to achieve efficacious treatment for liver disease.